Tyrosine kinase inhibition and immunomodulation for cancer

ABSTRACT Targeted molecular agents are a major advance in cancer therapy. The tyrosine kinase inhibitor imatinib mesylate targets the mutant KIT protein in gastrointestinal stromal tumor (GIST). However, while imatinib is highly effective against metastatic GIST, it almost never induces a complete response. Tumor progression occurs at a median of approximately 20 months and most patients eventually die from their disease. We have found that a novel tyrosine kinase inhibitor called PLX3397 is substantially more effective than imatinib in a genetically engineered mouse model of GIST and in human xenografts. After treatment, there is just a small fraction of residual tumor cells. Given that we have previously found that the immune system contributes to the efficacy of imatinib in GIST, we propose in Aim 1 to define the immune response after PLX3397 therapy in mouse GIST. Since PLX3397 causes much greater tumor destruction than imatinib, we hypothesize that the anti-tumoral immune response is greater. To eradicate the few remaining cells after PLX3397 treatment, we will combine it with the immunomodulatory agents anti-CTLA-4 or anti-PD-1 in Aim 2. The effect on tumor size and the antigen-specific CD8 T cell response will be assessed. In Aim 3, we will determine whether human intratumoral CD8 T cells that are freshly isolated from surgical specimens are functional against GIST. We anticipate that our findings will increase our understanding of GIST and may establish the rationale for a novel clinical trial combining molecular and immune therapy in GIST. We expect that our work will not only improve the lives of patients with these tumors, but also be relevant to other cancers in which targeted molecular therapy is used.

Public health relevance
PROJECT NARRATIVE Targeted molecular therapies are a landmark achievement in cancer treatment. Imatinib mesylate is one such therapy, which is remarkably effective against gastrointestinal stromal tumor (GIST), a solid cancer of the stomach and intestines. However, imatinib does not cure the disease and resistance against the drug eventually develops. We have identified a drug that is more effective than imatinib. The goal of the current research is to determine if and how immune therapy may enhance the anti- tumor effects of this new agent to achieve complete eradication of GIST. The results may provide the rationale for a new clinical trial combining molecular and immune therapy in patients with GIST, as well as an approach that can be applied to other types of cancer in which targeted molecular therapy is used. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Targeted molecular agents are a landmark achievement in cancer treatment. The tyrosine kinase inhibitor imatinib mesylate targets the mutant KIT protein in gastrointestinal stromal tumor (GIST) and achieves a partial response or stable disease in over 80% of patients with metastatic GIST. However, the drug almost never induces a complete response, and tumor progression occurs at a median of approximately 20 months, often due to a secondary mutation in the KIT gene. PLX3397 is a novel small molecule inhibitor that targets KIT and CSF1R. We have preliminary data that PLX3397 causes much greater tumor destruction than imatinib in a genetically engineered mouse model of GIST and in human xenografts. Additionally, PLX3397 inhibits wild-type KIT. Previously, we found in mice and humans that imatinib induces an anti-tumoral immune response through inhibition of the immunosuppressive enzyme indoleamine 2,3-dioxygenase (IDO). We hypothesize that the increased tumor destruction caused by PLX3397 will lead to a greater anti-tumoral immune response, which can be exploited by using concomitant immunotherapy. Our goal is eradicate the small population of cells that remain after PLX3397 therapy. The specific aims are to: 1. Define the anti-tumoral immune response to PLX3397 therapy. We found that PLX3397 therapy causes much greater tumor destruction than imatinib in our mouse model. Since we previously found that imatinib works partially via the immune system, we will investigate the anti-tumoral immune response after PLX3397 treatment. Mice with GIST will be treated with PLX3397, imatinib, or control and then the immune cell composition of the tumor, draining lymph node, and spleen will be determined. The dependence of PLX3397's effects on CD8 T cells will be determined in GIST mice depleted of CD8 T cells. 2. Determine if immunostimulation augments the efficacy of PLX3397. Previously, we found that anti-CTLA-4 is synergistic with imatinib. Now, we will test whether immunostimulation improves the results with PLX3397. In a mouse model of GIST, we will combine PLX3397 with anti-CTLA-4 or anti-PD-1 and measure the effects on tumor size and the antigen- specific CD8 T cell response. The mechanism will be studied by depleting CD8 T cells. 3. Establish whether immunomodulation increases intratumoral T cell function in human GIST. We will attempt to correlate our mouse findings regarding intratumoral CD8 T cell function to intratumoral T cells that are freshly isolated from human surgical specimens of GIST. We will undertake an extensive analysis of intratumoral T cell subsets in GIST. We will isolate CD8 T cells from human GISTs and block CTLA-4 or PD-1 in vitro to determine if CD8 T cell anti-tumor effects can be increased. We expect that our findings will enhance our understanding of the immunologic mechanisms involved in PLX3397 therapy and may establish the rationale for a novel clinical trial combining molecular and immunotherapy in GIST. We expect that our work will not only improve the lives of patients with GIST, but also be relevant to combining molecular and immunologic therapy in other types of cancer as well.